A systems-level approach to probe the effect of a high- fat/high-protein diet in Clostridioides difficile infection

PROJECT SUMMARY
Clostridioides (formerly Clostridium) difficile infection (CDI) is the leading cause of healthcare-associated and
antibiotic-associated infections in all age groups in North America. In the U.S., there are ~500,000 cases of CDI
annually, and over 25,000 deaths per year are attributed to CDI. CDI prevention and treatment costs the
healthcare system an estimated $6.3 billion/year.
The predominant risk factor for CDI is the use of broad-spectrum antibiotics and can be directly attributed to
disruption of the intestinal microbiome. Diet also exerts strong controls on the structure and function of the gut
microbiome; however, the role of diet in CDI risk and severity is not well understood. Existing reports are
contradictory regarding the effects of diet on CDI.
We have conducted initial experiments on the effect of diet on CDI using a mouse model of antibiotic-associated
CDI. Strikingly, our studies showed that mice fed a high-fat/high-protein, Atkins-like diet suffered 100% mortality,
whereas mice fed a high-carbohydrate diet developed few or no signs of disease. In this proposal, we will test
the hypothesis that a combination of host and pathogen responses to a high-fat/high-protein diet, within the
context of a depleted microbiome, together promote an environment conducive to C. difficile pathogenesis. In
Specific Aim 1, we will determine whether the high-fat/high-protein diet, alone or in combination with antibiotics,
induces inflammation and increased intestinal permeability prior to exposure to C. difficile. We will also document
changes in lumen metabolites and assess CDI severity and mortality compared to an improved matched-
ingredient, high-carbohydrate diet. In Specific Aim 2, we will probe the structure and function of the microbiome
using both metagenomics and metatranscriptomics at each stage of the experiment (diet only, diet plus
antibiotics, diet plus antibiotics and CDI) to explore the hypothesis that antibiotic treatment leads to the absence
of a few specific competitors for amino acids that leads to an open niche for C. difficile overgrowth. We will also
specifically examine relationships between the C. difficile transcriptome and changes in metabolite pools to
delineate two different metabolic states that define CDI outcome, leading to either fulminant CDI and mortality
and an asymptomatic carrier state. As a result of this project, we will have a better understanding of the influence
of diet, particularly high-fat/high-protein diets, on the host and microbiome and how these diets mediate fulminant
CDI. A positive impact would eventually be better management of diet in high-risk individuals, especially during
antibiotic treatments, and possible pre- or probiotics for CDI.
1

Public health relevance
NARRATIVE The proposed research uses both traditional and systems-level approaches to probe both host and microbial responses to a high-fat/high protein diet that greatly increases the severity of Clostridioides difficile infection (CDI) in a mouse model of antibiotic-associated disease. The knowledge generated by the proposed research will help to better understand complex interactions between the host, micro- biome, and C. difficile that together govern the outcome of CDI. A long-term goal will be to better man- age both diet and microbiome for humans at high risk for CDI. 1